Multilevel Drivers of Oral Health: Psychosocial Stress, Health Behaviors, and Neighborhood

PROJECT SUMMARY/ABSTRACT
There are over 62 million Latinx/a/o people living in the United States (U.S.) making them the largest
minoritized ethnoracial group in the nation. This large and growing group of people faces considerable
disparities in oral health, particularly among its adult population. For example, data from the National Health
and Nutrition examination survey for 2009-10 and 2012-12 shows that Latinx/a/o adults had the highest
prevalence of periodontal disease among adults of all ethnoracial groups. Studies examining the factors driving
oral health disparities within this population group have largely focused on the complex phenomenon of
acculturation, which broadly refers to the process of adopting U.S. mainstream culture’s attitudes, values,
customs, beliefs, and behaviors. However, cultural explanations of oral health disparities through the lens of
individual-level cultural changes ignore the role of structural factors, such as immigration policy, in
(re)producing oral health disparities over the life course and across generations. Therefore, the purpose of the
proposed study is to examine how the daily manifestations of perceived vulnerability due to immigration policy
shapes the oral health of Latinx/a/o adults. Using a mixed-methods approach, our specific aims to advance this
undertheorized area of research are to: (1) examine the association between self-perceived immigration policy
legal vulnerability and clinical and self-reported oral health and (2) explore the racialization experiences of
Latinx/a/o immigrant adults and their U.S. born co-ethnics to identify the sources of immigration policy
vulnerability that shape their oral health. The knowledge generated from this study is the first step towards
understanding the mechanisms by which the structural racialization of Latinx/a/o/ people via immigration policy
affects their oral health. This study is innovative as it will help redirect disparity-reduction efforts in the oral
health field away from the prominent individual-level cultural framework and towards the broader socio-legal
regimes that sustain inequity. This application will also contribute to the NIDCR’s 2021-2026 strategic plan goal
to advance the scientific methods to quantify disparities and inequities in dental, oral, and craniofacial health
and disease.

Public health relevance
PROJECT NARRATIVE Oral health is essential for the overall health well-being of adults yet oral diseases remain prevalent within this population group, particularly among adults of Central and South American ancestry. This study will examine how everyday daily life experiences shaped by upstream psychosocial factors affect oral health among adults of Central and South American ancestry. These findings will expand our understanding of how broader upstream factors contribute to oral health patterns among the adult population in the United States.